Temporal Context in Brains and Transformers

Project Summary:
Long-term working memory allows us to remember what was said and seen on the slides at the end of a lecture,
what was read in a book after long sequences of saccadic eye movements, and the musical progression during
a symphony. The interplay between long-term memory retrieval in many cortical areas is involved. However, the
neural mechanisms that allow us to integrate new detailed information and keep it fresh in mind over minutes
and hours are unknown. Brains extract meaning from the temporal context of words in a sequence. This Pioneer
Award aims to discover how global dynamical activity in the cortex and medium-term synaptic plasticity in cortical
circuits create temporal context extending over minutes and hours.
Transformers in Large Language Models can also keep temporal context over long dialogs and documents
by storing them in a long input vector, simultaneously making all past information available. Brains don't have
digital memories like computers, but nature could have evolved alternative mechanisms. Multichannel recordings
have revealed traveling waves of neural activity in multiple sensory, motor, and cognitive systems. Traveling
waves are ubiquitous in the cortex and carry information from the past to the future. My working hypothesis is
that cortical traveling waves may be a dynamical version of the long input vector in transformers. Spacetime
coding by cortical traveling waves is complementary to the rate code used for well-studied, fast sensorimotor
processing. It could be used in sensory and memory systems to organize the global processing and storage of
new memories over minutes and their retrieval and maintenance over hours.
A cortical neuron that receives direct sensory input from the thalamus also receives indirect inputs from
distant neurons in the form of a traveling wave delayed by slow, unmyelinated, long-range horizontal
connections. Mixing present and past information creates a new type of spacetime population code that
simultaneously represents neural activity occurring within a time window and provides temporal context between
past and present inputs. The time windows for spacetime codes will vary over the cortex, from 100 ms in V1 to
minutes in the prefrontal cortex. However, another mechanism is needed to extend long-term working memory
to hours. The frequencies of cortical waves during awake states range from 10 to 40 Hz, which can trigger the
suboptimal induction of spike-timing-dependent synaptic plasticity (STDP) lasting 20-60 minutes. This matches
the time window for long-term working memory and has the advantage that it can be reused.
Long-term working memory will be simulated and studied in two-dimensional very-large-scale models
(VLSMs) of the spiking recurrent cortical networks that support traveling waves and STDP. Experimental
collaborators will test predictions from the models in rats, monkeys, and humans. New analytic techniques will
be needed to decode the spacetime code from cortical recordings from a wide range of cortical areas.

Public health relevance
Project Narrative: Mental disorders and neurological diseases, which affect perception, memory, decision-making, thought, actions, and sleep, cause great anguish and financial loss for the US. Mental disorders are neural circuit diseases that are difficult to treat because we do not yet know enough about the long-term flow of activity in cortical circuits responsible for working memory lasting for hours. The proposed pioneering research will use advanced computational techniques to analyze and model local and global multielectrode recordings of neural activity in cortical circuits of rats, monkeys, and humans responsible for long-term working memory, which will help us understand how cortical activity is compromised in patients with thought disorders in schizophrenia, confusion in traumatic brain injury (TBI), and memory intrusions in post-traumatic stress disorder (PTSD).